Lesbian, Gay, Bisexual and Transgender Health Issues and Research Gaps and Opport

An IOM committee will conduct a review and prepare a report assessing the state of the science on the health status of lesbian, gay, bisexual, and transgender (LGBT) populations;identify research gaps and opportunities related to LGBT health;and outline a research agenda that will assist NIH in enhancing its research efforts in this area. Additionally, the committee will consider research training needs to foster the advancement of knowledge about LGBT health and identify impediments that hinder such advancement.